Administrative Core

PROJECT SUMMARY (Administrative Core)
The Administrative Core of the Center (directed by Dr. Deisseroth) shoulders the complex burden of coordination
and communication across projects, cores, collaborators, and visiting scientists; manages financial,
administrative, approval, and safety issues; and oversees and implements data sharing and dissemination. For
a Center breaking technological barriers, while also teaching and training in existing technologies, and using all
of these technologies to discover new principles regarding drug action on the brain, a robust and well-integrated
Administrative Core is fundamental to rigorous, safe, stable, and effective implementation. Monthly full meetings
and weekly subgroup meetings require steady and experienced staff to coordinate. The Center by necessity also
includes substantial complexity in terms of personnel, finances, and safety. The diverse network of staff
scientists, graduate students, postdoctoral fellows, collaborators, and training activity is essential to the Center
and requires an able Administrative Core to implement, track, manage, and report. These efforts include
managing compliance and approval on human subjects research, animal protocols, safety inspections, DEA and
drug use regulations, progress reports, publication management; financial projections, reimbursements, auditing,
and accounting; and interactions with University resources that are leveraged. Finally, the greatest opportunity
of the Center—sharing of data and technology-- is also its greatest challenge. The Center web pages, wikis, and
online forum (next-generation implementations of our existing small efforts in this direction) are another high-
impact and challenging administrative element. As with the other Cores and the Projects, this Core stands in
part upon well-established human and other resources, but expands and diversifies in fundamentally new
directions under the auspices of the P50 and of NIDA. Success of the Center ultimately is measured in terms of
both the science and the outreach; the Administrative Core is absolutely crucial for both. To achieve its stated
goals in the most efficient and cost-effective manner, the Center requires an Administrative Core that provides
administrative support to all Center investigators and assists in the dissemination of reagents and findings
generated by the Center.